Assembly and characterization of human cortico-striatal neural networks

Disruptions of cortico-striatal network have been identified in association with many neurological and psychiatric
brain disorders, including Phelan-McDermid syndrome, a rare neurodevelopmental disorder caused by genetic
abnormalities in SHANK3. In this project, we will investigate the cellular and molecular mechanisms that regulate
the development of cortico-striatal connectivity in organoids under normal conditions and in association with
SHANK3 deficiency. We will generate cortical, striatal, and cortico-striatal organoids from control and isogenic
SHANK3-deficient deficient stem cells and characterize their cellular composition (Aim 1) and functional
connectivity (Aim 2). We will use “cutting-edge” techniques such as single-cell mRNA sequencing and chronically
implanted multi-electrode probes to investigate the cellular and molecular mechanisms that are regulated by
SHANK3. As most brain disorders impact several brain regions and disrupt interregional brain communication,
the ability to generate organoids representing multiple brain regions that replicate the complex nervous system
architecture and physiology will constitute a major breakthrough in brain disease modeling and drug discovery.

Public health relevance
Cortico-striatal networks are affected in many neurological and psychiatric disorders. This project will investigate the development of human cortico-striatal connectivity under normal and pathological conditions using stem cell-derived cortico-striatal organoids. The ability to create disease-related cortico-striatal organoids will provide a new approach to enable the development of new diagnostics and treatments.